Accelerating Interventions for Craniofacial Diseases and Disorders via DSPP Scholar Training at Michigan

ABSTRACT
Craniofacial diseases and disorders (CDD) are common birth defects with significant physical,
psychological, and financial ramifications on the affected, their families, and their society. The multidisciplinary
craniofacial clinics and centers providing comprehensive care for patients within networked health care
systems have greatly improved the assessment, diagnosis and management of patients with CDD. However,
due to the complexity and vulnerability of craniofacial developmental process, the genetic, environmental and
developmental causes of many craniofacial disorders remain unknown constituting the most effective barrier
for prevention and interventions.
The goal of this clinician-scientist training program is to nurture scholars who are passionate about serving
patients with CDD and interested in expanding scientific knowledge and effective intervention of CDD. Such
goal will be achieved by building a pipeline of scholars, recruiting committed scholars, and providing a training
environment to ensure academic excellence and professional success of these scholars. Specifically, our
program will offer PhD training via core courses, seminars, journal clubs, research investigation, scientific
writing, career and leadership development, coupled with clinical specialty training that supports scholars’
scientific and career goals. The PhD training will be integrated with the Oral Health Sciences PhD program and
specialty training will be conducted within one of the accredited specialty programs at the School of Dentistry.
Clinical and research mentors with expertise and experiences have been assembled. We propose to admit two
scholars to pursue the integrated dental specialty and PhD training. Scholars will be selected based on strong
academic records, research accomplishments, and commitment to a research-intensive academic career with
a focus on craniofacial diseases and disorders. Specific efforts will be made to recruit individuals from
underrepresented backgrounds, as well as disadvantaged and disabled individuals. Each scholar’s academic
plan will be individually tailored and funding plan established at matriculation by considering scholar’s abilities,
experiences, and requirements of his/her chosen specialty.
This multidisciplinary program that spans across departmental and school boundaries will involve the
School of Dentistry, Rackham School of Graduate Studies and the University of Michigan Central campus
where in addition to the core curriculum in oral sciences, selected didactic, clinical, and research training will
take place. Scholars will receive formal instruction in responsible conduct of research and scholarship. The
University of Michigan values quality training programs and is committed to training dentist-scientists to
become independent researchers, skilled clinicians, critical thinkers, and life-long learners, thus developing a
diverse and uniquely qualified workforce that will accelerate the prevention and interventions of craniofacial
diseases and disorders.

Public health relevance
Project Narrative This Dental Specialty and Ph.D. Program (DSPP) proposal presents an integrated program that’s constructed to build advanced knowledge and skill sets in scholars who aspire to become clinician-scientists to advance our understanding of craniofacial diseases and disorders. Integrated in the program plan of the DSPP training are graduate core courses, biomedical core courses, advance science courses, research training, specialty residency education, interactive instructions in Responsible Conduct of Research and Scholarship, leadership and professional development. With the full commitment of the faculty team, the OHS program, the specialty programs, the School of Dentistry, and Rackham School of Graduate Studies, our ultimate goal is to prepare the scholars to become leaders, educators, and researchers in the field of craniofacial diseases and disorders to advance academic dentistry and public health.